The Role of Lymphoid Neogenesis in the Maintenance of Lung Transplant Tolerance

PROJECT SUMMARY / ABSTRACT
Pulmonary transplantation remains the only available treatment for numerous patients, who suffer
from end-stage lung disease. However, outcomes after lung transplantation continue to be
substantially worse than those after transplantation of other organs. Current immunosuppressive
strategies for lung transplant patients are based on protocols that have been successfully used
for recipients of other organs. However, such approaches do not account for fundamental
differences between immune responses to lung grafts and other commonly transplanted solid
organs. Utilizing new mouse models of lung transplantation we have uncovered that tolerance to
pulmonary grafts is regulated locally through interactions of immune cells within lymphoid
aggregates that are newly formed in the graft. We have reported that disruption of
immunoregulatory circuits in tolerant grafts results in the local activation of graft-infiltrating
lymphocytes, which triggers rejection. This application proposes to study mechanisms how
tolerance is maintained at the level of the graft microenvironment after pulmonary transplantation
and will allow for the development of new therapies for lung transplant recipients.